Insulin Signaling Activates Urothelial Defenses to Reduce Urinary Tract Infection Susceptibility

Project Summary/Abstract:
Diabetes mellitus is associated with many complications, including increased infection risk. With diabetes, one
of the most common sites of infection is the urinary tract. In people with diabetes, urinary tract infection (UTI) is
more common and has worse outcomes. The mechanisms that predispose people with diabetes to UTI are not
defined. A greater appreciation for the host defense mechanisms that protect the urinary tract from microbial
insult is needed to develop new UTI prevention and treatment strategies. This application’s objective is to identify
how insulin signaling regulates innate immune defenses in the bladder. Our published and supporting data
demonstrate that bladder urothelial defenses are regulated by insulin-mediated targets, including peroxisome
proliferator-activated receptor-γ (PPARγ), insulin receptor signaling, and histone deacetylase proteins.
Specifically, our data suggest PPARγ activation and histone deacetylase inhibition enhance insulin signaling,
strengthen the urothelial barrier, and enhance innate immunity, including the production of antimicrobial peptides
and the urothelial barrier. In contrast, silencing urothelial insulin receptor expression increases UTI susceptibility.
These data support our central hypothesis that insulin and insulin receptor signaling have key roles in activating
innate immune responses and regulating UTI host defense. Expanding upon these findings, we propose a
comprehensive analysis of insulin’s ability to regulate bladder urothelial defense mechanisms. Aim 1 will
determine the effects of progressive insulin resistance and diabetes on the bladder’s antibacterial defenses. We
will also investigate if activating PPARγ triggers insulin signaling to enhance immune defenses and reduce UTI
susceptibility. Aim 2 will interrogate the impact of insulin receptor signaling on the bladder’s immune defenses
and urothelial responses and repair to UTI. Aim 3 will define the effect of histone deacetylase proteins on insulin
signaling and the bladder’s immune defenses. Our long-term research goal is to identify why people with diabetes
have increased UTI risk and improve their care. By evaluating the role of insulin signaling in host defense, our
expected outcomes may have profound influence on human health as they may develop insulin-signaling targets
as new UTI therapeutics.

Public health relevance
NARRATIVE Urinary tract infections are serious infections that can cause many health complications and death in people with diabetes. Research suggests that cells in the bladder are important for fighting urinary tract infections. By studying how insulin resistance and diabetes impact the antibacterial mechanisms in these bladder cells, we can gain insight into why people with diabetes develop infections and identify new options to treat and prevent them.